Effects of age and social adversity on immune status and responsiveness in a non-human primate model of human aging

Project Summary
The average human lifespan has almost doubled over the past century, leading to an increase in the prevalence of
diseases of aging, such as cardiovascular disease, arthritis, cognitive decline and autoimmune disorders. Aging is
associated with a decline in adaptive immune function and an increase in inflammation, which underlie many
age-related diseases. These immunological changes are similar to those seen in individuals exposed to social
adversity, who may age more rapidly than those unexposed. Yet, it is unclear how social adversity alters immunity
across demographic factors - data that are essential to identify how it might increase aging-related diseases. The
central objective of this proposal is to identify the specific cell types and molecular markers of the immune
system that contribute to the aging process and how social adversity shapes the function of these cells and
markers. To test this, I draw on a longitudinal study of free-ranging nonhuman primates – the Cayo Santiago
rhesus macaques. These animals present a unique opportunity to examine aging and its social determinants. First,
rhesus macaques have a strong phylogenetic proximity to humans and show very similar aging trajectories,
making them an exceptional model for human health. Second, rhesus macaques form stable social structures that
dictate individuals' access to resources and peers, similar to human populations- making this species an ideal
model in which to study the potential effect that social adversity has on accelerating aging. The central
hypothesis of this proposal is that social adversity leads to an impaired immune system, recapitulating the
effects of aging, which consequently accelerates the biological signatures of aging independently of an
individual’s chronological age. To test this hypothesis, I will collect data from the Cayo Santiago rhesus
macaque population over two years, totaling a sample size of 200 individuals. Aim 1 of this proposal will measure
and explore how both age social adversity and age alter immunity at baseline by measuring different immune cell
types – both lymphocytes and monocyte subpopulations- using flow cytometry. Aim 2 of this project will test
how age and social adversity alter the immune response to an infection, and if they do so in a similar way. Here,
we will create a pro-inflammatory (Th1) and anti-inflammatory (Th2) immune response by isolating and
stimulating peripheral blood mononuclear cells (PBMCs) using live pathogens and pathogens molecules. In recent
years, it has become clear that the social environment plays a critical role in the development and overall health
across different species. By combining physiological data and behavioral observations, the proposed project will
generate data that is necessary to understand the role that social adversity may play in inducing aging-related
changes in immunity. Ultimately, this project will reveal how the social environment alters the pace of aging,
which will inform the targeted development of social and physiological interventions that could reduce the burden
of aging-related disease in our aging population.

Public health relevance
Project Narrative Aging is accompanied by changes at the organ as well as at the systemic level; one hallmark of aging is decline in immune function and increases in inflammation that hinder the immune response. Because there is great heterogeneity in aging trajectories, there is a need to understand what factors cause certain individuals to age faster, and in recent years research has shown that the social environment may affect the pace of aging. By using a non-human primate model that has similar aging trajectories to humans, this project will investigate if and how accumulation of social adversity may induce aging-related changes in immunity (both at baseline and in response to a stimulation), making social adversity a key component in the development of aging-related diseases and a possible target of behavioral interventions to prevent or mitigate them.